Statistical Methods In Human Development/clinical Studies

Data collection for a study of the effects of soy estrogen on neonatal development carried out at Children's Hospital of Philadelphia has been completed (collaboration with Walter Rogan, formerly EB, now retired). We have recently published a paper that examined trajectories of anti-Mllerian hormone across infancy in girls; we used latent-trajectory techniques to cluster infant girls into four trajectory classes that differed in shape and found that girls in these derived classes differed in their FSH trajectories, their timing of estradiol production, and their ovarian characteristics. We are currently undertaking comparisons of testis volume measured by ultrasound with testicular volume assessed via Prader orchidometry. We are also studying possible associations of phenol exposure measured in urine with differences in infant growth trajectories, focusing initially on longitudinal measures of BMI z-score calculated from World Health Organization growth standards.